FAMILY HEALTH--EXPLORATIONS FOR SCHOOLS AND COMMUNITIES

DESCRIPTION (Adapted from applicant's abstract): This project is a collaboration between the Lawrence Hall of-Science (LHS), a public science and technology center, and the Schools Wellness Program (SWP), both at the University of California (UC) at Berkeley. This model program will develop and disseminate hands-on activities and follow-up materials clustered around four major health science areas: nutrition and growth, respiratory health, disease prevention, and mental health and the brain. Through a series of Leadership Training Workshops, the program will partner health care professionals with teachers, parents, youth, and community educators, to form leadership teams for disseminating the Family Health materials. One motivational hook and introduction for the program will be a Medical Mystery Festival that draws children and adults through a series of engaging hands-on activities that simulate medical investigations. The festival will be accompanied by activities related to fitness and personal risk assessment that can easily be taught in community settings by parents and youth, and by teachers in school classrooms. A second motivational component is LHS YouthALIVE! Theater in which secondary school students present skits featuring health issues of high interest to students and families. Participating schools will use the festival and skits as the kick off for a school-wide program of on-going activities that teach children: 1) science principles related to health, 2) decision-making skills that promote healthy choices, and 3) leadership skills that promote participation in healthy activities. In year one, the model will be pilot-tested in four schools that comprise an elementary, middle school and high school feeder system in Oakland, California. In years two and three, the model and materials will be refined and extended to eight additional schools in Oakland and San Francisco. The Leadership Training Workshops will directly serve 60 teachers, 60 parents, and 60 health care professionals who will be partnered in teams to lead and teach programs for their schools. Sixty secondary school students will be trained to present YouthALIVE! Theater programs in their neighborhood schools and to an estimated 15,000 families participating in community events in the San Francisco Bay Region. The Medical Mystery Festival, YouthALIVE! Theater and follow up health curriculum will be presented to an estimated 9,000 school children and their teachers. Information and sample activities for the Family Health model will be made available nationwide through an interactive Web page and the TAPPED-IN virtual conference center at LHS.